Neuroimaging Core

Summary (Neuroimaging Core)
The purpose of the Center for the Study of Aphasia Recovery (C-STAR) is to better understand how aphasia
therapy and factors such as genetics, serotonin, and brain health influence aphasia recovery. The proposed
work acquires brain imaging data in multiple modalities at different time points following stroke. The mission of
the Neuroimaging Core is to integrate data from each of the clinical sites to optimally support the objectives of
the research projects. First, the neuroimaging core will receive, deidentify and archive neuroimaging and
behavioral data from each clinical site. Second, the Neuroimaging Core will be responsible for processing
these data using state-of-the-art tools. Third, the Neuroimaging Core will support and refine the tools we have
developed to better allow each research team to analyze their data and address specific research aims.
Fourth, the Neuroimaging Core will provide tools that aid in visualization of brain data. The Neuroimaging Core
will make it possible for outside investigators to leverage the tools and data associated with this project. The
proposed work will allow the neuroimaging team to continue to refine, validate, showcase, and disseminate the
tools required for each of the project aims.